Phase 2 study of Lu-177-DOTATATE in inoperable paraganglioma - pheochromocytoa

The goal of this project it to assess the safety and to evaluate the ability of Lu-177-DOTATATE to improve upon progression-free survival (PFS) at 6 months in patients with inoperable, SSTR positive PHEO/PGL by comparing PFS of patients treated with Lu-177-DOTATATE to historical controls from existing literature. In the last year, we have been preparing the manuscript for publication and have submitted the manuscript to a for peer-reviewed journal for publication, so that we can share the results of our research with the scientific community.